Novel tools for measuring typhoid vaccine impact

Project Summary
Typhoid fever is a leading cause of invasive bacterial illness and death worldwide, with
the majority of infections occurring in low- and middle-income countries where water and
sanitation infrastructure is poor. Highly antimicrobial-resistant strains of Salmonella
Typhi have been emerging and spreading internationally and intercontinentally, posing
the risk of rising morbidity among reduced effectiveness of therapy. New typhoid
conjugate vaccines have demonstrated a high level of effectiveness and are
recommended by the WHO; however, many countries lack data on typhoid incidence, as
the only reliable tool for typhoid diagnosis—blood culture—is not widely available in
many resource-constrained settings where typhoid risk may be greatest. To address
these gaps, we propose to leverage a large, cluster-randomized trial of a typhoid
conjugate vaccine being performed in Vellore, India, to test three emerging tools to
measure community burden of typhoid: 1) seroepidemiological models, utilizing recently
characterized seroresponses to S. Typhi antigens; 2) detection of S. Typhi-specific
bacteriophages in wastewater, using low-cost assays; 3) phylodynamic methods that
track measures of transmission intensity. This project will provide rigorous testing of
multiple innovative methods amid uniquely intensive clinical surveillance in a vaccine
trial. Overall, this project will address a critical need for public health tools to make
typhoid surveillance scalable in resource-constrained settings, to inform vaccine
introductions and monitor their impact.

Public health relevance
Project Narrative Typhoid fever is among the most common invasive bacterial illnesses worldwide, and new conjugate vaccines have demonstrated a high degree of effectiveness in preventing this disease. There is a need for improved tools to understand where typhoid fever burden is greatest, to prioritize vaccine introductions and monitor their impact. This project leverages a cluster-randomized typhoid conjugate vaccine trial to investigate three novel tools—serological, wastewater surveillance, and phylodynamic—to characterize typhoid transmission intensity and evaluate vaccine impact, with a goal of identifying scalable strategies to monitor typhoid burden worldwide.